Quelling UPEC Proliferation by Lactobacillus Mediated Induction of Latent Phages

Prior studies have found that several Lactobacillus species inhibit the growth of or kill
uropathogenic Escherichia coli (UPEC). Lactobacillus crispatus, L. gasseri, L. iners, and L.
jensenii are frequent dominant members of both the healthy female vaginal and urinary microbiota
and have been associated with the lack of lower urinary tract symptoms, including urinary tract
infections (UTIs). Urinary Lactobacilli produce hydrogen peroxide (H2O2) and lactic acid, both of
which can stress the UPEC cell and are attributed to reduced colonization within the bladder. As
phage biologists and the first group to investigate phages within the urobiome, we recognized an
immediate connection between Lactobacillus-dominated environments and temperate phage
induction. Our prior genomic survey of bacteria in the urinary tract (urobiome) found that most
bacterial genomes have latent (integrated) phage genomes, and our prior empirical work suggests
that most of these latent phages are in fact temperate phages capable of being induced. The
induced phage excises from the bacterial genome, replicates, and lyses (kills) its bacterial host
cell. Our proof-of-concept work found: (i) cell-free Lactobacillus supernatant can induce UPEC
latent temperate phages (coliphages), (ii) liquid cultures at Lactobacillus-relevant pH values can
induce UPEC temperate coliphages, and (iii) liquid cultures at Lactobacillus-relevant H2O2 levels
can induce UPEC temperate coliphages. This leads to our hypothesis: Lactobacilli may control
UPEC colonization via “lysis from within” – H2O2 and/or pH stress UPEC strains, which
leads to induction of resident temperate coliphages and death of the UPEC cell.
Taking an interdisciplinary approach, the proposed project will assess the frequency and
cause of induction of UPEC coliphages by Lactobacillus. Aim 1 will expand our preliminary work
to determine if the cell-free supernatant of all common urinary Lactobacillus species induces
UPEC coliphages; multiple strains of L. crispatus, L. gasseri, L. iners, and L. jensenii will be tested
on a large collection of E. coli isolated from the bladders of females with and without LUTS,
including UTI. In Aim 2, we will ascertain if phage induction triggered by cell-free Lactobacillus
supernatant is the result of stress triggered by pH and/or H2O2 levels. Additionally, we will
determine how pH and H2O2 impact UPEC growth over time. Our investigation will determine what
role phage induction plays in shaping the urobiome community. Understanding the mechanisms
that control UPEC colonization can inform clinical care of acute UTIs.
This project is proposed as an R15 AREA for Undergraduate-Focused Institutions and is
designed to engage undergraduates in interdisciplinary research of benign urologic disease.

Public health relevance
While prior studies have found that several Lactobacillus species inhibit the growth of uropathogenic Escherichia coli (UPEC) and protect against UTI development, the mechanisms in which this occurs have yet to be thoroughly investigated. Our recent work found that Lactobacillus-mediated metabolites can cause latent phage induction in urinary E. coli isolates, which results in lysis (death) of the host E. coli cell. The proposed AREA project integrates bioinformatic, statistic, and microbiologic techniques to explicitly explore the extent and mechanisms of Lactobacillus-mediated induction of latent phages on UPEC colonization.